CIVM ASSISTANCE WITH BRUKER 70 T 210 HORIZONTAL BORE IMAGING SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. On an as-needed basis, staff from the Center for In Vivo Microscopy assist Dr. Warren Warren's graduate students with operation of their Burker, 7T MR system, animal support, and ventilation matters.